Administrative Core

Core A will continue to provide scientific, fiscal, administrative, and logistic oversight to all aspects
of the Center. As before, Core personnel will facilitate communication among investigators and
the sharing of reagents, tools, specimens, and data to ensure appropriate allocation and effective
use of Center funds. The Core will also continue to: provide clerical support; coordinate
interactions between facility cores and research projects; organize regular investigator meetings
and; provide biostatistical support. In addition to these functions, the Core will develop and
implement a clear path for transition to and attainment of independent status of the Cores. The
Core will provide leadership and administrative support needed to maintain the thematic focus of
the Center and to achieve Center goal. It will provide oversight to a pilot project program that
provides seed funding for promising projects by new investigators. Core personnel will encourage
the exploratoin of new research avenues and phase out unpromising resarch and maximize the
intellectual environment of the Center. The Core will also provide statistical support to assist in
study design and analysis and help in developing grant proposals and maintain data and
biospecimen biorepositories. It will monitor evaluate overall Center progress in achieving specific
milestones. Core personel will prepare annual scientific reports and financial statements and plan
and organize symposia, seminars and regulary-scheduled meetings. They will invite prominent
scientists to present seminars and interact with Center members and communiate with University
and NIH officials to report progress and discuss Center related issues. In consultation with the
external and internal advisory committee, the Program Director will evaluate core progress and
the achievement of Center goals. If required, Core A personnel will work with university officials
to increase the critical mass of investigators working in the Center. If it becomes necessary, Core
A will adopt remedial measures for Principal Investigators who fail to satisfactory review by the
External Advisory Committee. The Core will also maintain a Center Website and faciliate the
dissemination of information about Center activities as well as diabetes and obesity.